Core C: Atherosclerosis and bioinformatics core

Abstract
The Atherosclerosis and Bioinformatics Core (Core C) within the Program Project grant “Triglycerides,
Diabetes and Cardiovascular Disease” will provide all three individual Projects with expertise in pathology-
based analytical techniques to evaluate atherosclerotic lesions. Techniques include histological staining and
immunohistochemistry. The Core will also provide expertise in RNA-seq, single-cell RNA-seq, and CITE-seq
bioinformatics analyses as a complement to the Program Project investigators’ projects. This Core’s repertoire
of high-quality analyses of atherosclerosis will substantially enhance the scientific progress of the three
individual projects.